BIOLOGICAL CONSEQUENCES OF ALTERED GENE EXPRESSION IN BREAST CANCER

Transfection experiments have defined the contribution of several genes to breast tumor progression. Thrombospondin is an extracellular matrix component with multiple biological functions. We transfected a wild type and C-terminally truncated forms of thbs-1 cDNA into the MDA-MB-435 breast carcinoma cell line, and examined its in vivo and in vitro behavior. The wild-type thbs-1 transfectants produced smaller primary tumors in the mammary fat pads of nude mice, and fewer metastases than either control transfectants or a C-terminally trucated thbs-1 transfectant. Expression of the wild type thbs-1 was accompanied by inhibition of endothelial growth in vitro as well as reduced capillary densities in vivo, suggestive of an angiostatic function. Transfection of the c-erb-B-2 oncogene into MDA-MB-435 breast carcinoma cells, at levels comparable to those observed in human tumors, resulted in no significant change in primary tumor size, but a 2-5 fold increase in tumor metastatic potential. The erb-B-2 transfectants failed to exhibit increased in vitro growth, colonization or motility as compared to the control transfectants, but responded to its putative ligand, Heregulin, in motility assays.